Leveraging Longitudinal Survey and EHR data to Dissect the Impact of COVID-19 related Stressors and Infections on Child Mental Health and Suicide Risks

The adverse impact of the COVID-19 pandemic on child mental health has become a public health priority.
Suicidal ideation and suicide attempts among children increased by 70-130% in 2020-2021 compared to the
pre-pandemic period. Pre-existing social determinants of health (SDoH) and changes in pandemic-related
SDoH have exacerbated child mental health disparities. However, the long-term impact of COVID, including
Long COVID, the broader secondary impact of the lingering pandemic, and pandemic policies on child mental
health, is largely unknown. It is urgent and time-sensitive to identify high-risk children and modifiable targets to
reduce COVID-related new/worsening mental health and suicidal ideation and suicide attempts that could have
major consequences for the transition to adulthood. This proposed project will identify urgent and modifiable
factors to alleviate the negative impact of COVID-19 on child mental health. Our specific objective is to
examine the long-term impact of pandemic-related SDoH and policies on child mental health and suicidal
ideation, and suicide attempts. Our central hypothesis is that children who were girls, racial/ethnic minorities,
with pre-existing mental illness, infected by SARS-CoV-2, and exposed to greater SDoH and containment
policies will have new and worsening mental health and suicidal ideation and suicide attempts in the long term.
These hypotheses have been formulated on the basis of our strong preliminary data from the proposed
population-level data from the Adolescent Brain Cognitive Development study (>11000 children) and electronic
health records in the National COVID Cohort Collaborative (>170000 children). Our recent JAMA Psychiatry
study strengthens the evidence that pandemic-related SDoH worsened child mental health disproportionately
among those who were females, Black, Hispanic children, and those living in deprived areas. This R01
application will extend our prior empirical and methodological expertise in the following specific aims: 1)
quantify new and worsening child mental health and suicidal ideation and suicide attempts, as well as their
trajectories across the COVID pandemic. 2) examine the direct and indirect (mediation/moderation) impact of
pandemic-related SDoH on child mental health and suicidal ideation and suicide attempts, and 3) determine
the effects of COVID-19 policies on child mental health and suicidal ideation and suicide attempts. The key
innovation is to apply novel causal models from epidemiology and economics to estimate the long-term impact
of COVID-19 infections, pandemic-related SDoH, and policies on mental health and suicidal ideation and
suicide attempts among children from two large-scale, nationwide, longitudinal datasets. We will reduce data
dimensionality and create novel SDoH and policy indexes to capture the time-varying exposures to changes in
SDoH. Our findings will meet urgent and critical public health needs to prevent the widening mental health
disparities worsened by the COVID-19 pandemic, by refocusing on SDoH and informing structural and
psychosocial interventions. Addressing minority mental health is closely aligned with the NIMH Strategic Plan.

Public health relevance
The proposed research is relevant to public health because it is important for policy and clinical interventions to reduce disparities in child mental health and suicidal ideation/attempts. Identifying the long-term direct and indirect (mediation/moderation) impact of changes in pandemic-related social determinants of health and secondary effect of COVID-19 can guide actionable steps to prevent the widening racial/ethnic and sex gaps in child mental health and suicidal behaviors. The project closely responds to 1) PAR-22-113, which calls for addressing urgent, time-sensitive MH questions related to COVID-19, by identifying urgent and modifiable targets to reduce new and worsening child MH implicated by the pandemic; and 2) NIMH's research priorities and strategic goals of promoting research to improve minority health and identifying mental health trajectories, given its focus on determining the impact of COVID-19 pandemic SDoH and policies on mental health among children from two largest, nationwide, longitudinal child samples linked with population-level SDoH and policy data.